Assessing the Strength of Weak Ties

Even though the paradigm shift in structure biology, heralded by AlphaFold2 of the deep-learning era, has
transformed biological sciences, the true physics of the protein folding problem remains unresolved. For
example, predicting the effects of mutations on protein stability remains an outstanding challenge, even though
structure prediction is highly accurate. The lack of an understanding of the forces, especially the weak
interactions (e.g., p-interactions), for a proper description of protein biophysics, has continued leading to a lack
of comprehension of the impacts of disease-causing mutations, post-translational modifications (PTMs),
interactions contributing to protein aggregation, phase separation, etc. The continued existence of this
knowledge gap represents an important problem because, until it is filled, manipulations of weak interactions
for beneficial interventions will not be possible. An important step towards addressing this problem is correctly
identifying weak interactions in protein structures so that perturbations of such interactions through
experiments would facilitate a complete comprehension of their roles. To identify weak interactions, we
recently developed a web service, AQcalc, that correctly identifies a few weak interactions. Even with limited
capabilities, AQcalc revealed several novel interaction mechanisms in aggregation, disease mutants, PTMs,
etc. Our long-term goal is to understand the mechanisms of how weak interactions regulate macromolecular
structure and function. The scientific objective for this R15 application is to develop a comprehensive web
utility (AQcalc upgrade) that anyone can accurately and conveniently identify various weak interactions in the
structures of proteins and their complexes (DNA/RNA/lipid-bilayer/small-molecules) in the limitless structures
of the deep-learning era. The utility, for thoroughness, will identify weak interactions in the context of
conservation, sequence designability, and dynamics (CDD) that no other services provide. Furthermore,
convenient rapid experimental assay systems are also developed to facilitate hypothesis testing of the roles of
the identified weak interactions. Our rationale is that (a) accurate and comprehensive identification of various
weak interactions, as shown with strong preliminary results, will provide new insights by enabling subsequent
studies on proteins or other biomolecules by manipulating weak interactions, (b) the availability of convenient
rapid experimental assay systems will facilitate probing molecular mechanism of weak interaction. The two
specific aims are: 1) Upgrade the functional utility of AQcalc. 2) Experimentally investigate the perturbations of
weak interactions through rapid assays. The approach is innovative for integrating various important elements
(comprehensive identification, CDD thoroughness, and experimental probing) into a one-stop-shop platform
unavailable elsewhere. The research is significant because it is expected to vertically expand the
understanding of how weak interactions contribute to macromolecular structure and function. Comprehensive
knowledge of weak interactions will ultimately facilitate preventative manipulations of the human proteome.

Public health relevance
PROJECT NARRATIVE A comprehensive identification of various weak interactions in proteins and evaluating their functional roles using rapid experimental assays will lay a foundation to enhance our ability to comprehend how weak interactions regulate protein structure and function. The proposed research is relevant to public health because the knowledge is ultimately expected to enhance our manipulative ability to prevent aberrations and dysregulation of the human proteome. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to seeking fundamental knowledge about the nature and behavior of living systems for the application of the knowledge to enhance health.